Modeling Human Trophoblast Differentiation and Function Using Pluripotent Stem Cells

PROJECT SUMMARY/ABSTRACT
Trophoblast is the major epithelial cell type in the placenta and provides an essential maternal-fetal interface
during pregnancy. Understanding the specification and differentiation of the trophoblast lineage is vital for
improved diagnosis and treatment of placental complications, including implantation failure, preeclampsia, and
preterm birth. Trophoblast has historically been difficult to study in humans due to limited access to first-trimester
placental tissue and the inability of animal models to fully recapitulate human placental development. To enable
dissection of early mechanisms of human trophoblast development, we will leverage “naïve” human pluripotent
stem cells (hPSCs), which exhibit molecular signatures of pluripotent cells in pre-implantation embryos. We
recently showed that naïve hPSCs readily differentiate into human trophoblast stem cells (hTSCs), which can in
turn differentiate into specialized extravillous trophoblasts (EVTs) and syncytiotrophoblasts (STBs) or self-
organize into 3D organoids that encompass a diversity of trophoblast cell types. Here, we will combine these 2D
and 3D models of trophoblast development with epigenomic and single cell approaches to dissect the
mechanisms of human trophoblast differentiation and function. Importantly, we have already validated key
preliminary findings in human first-trimester placental tissues and will extend this in vivo validation to all the major
findings of this project. Aim 1 will establish an epigenome roadmap during the transition from naïve hPSCs into
hTSCs and their subsequent differentiation into specialized trophoblast fates. This work will identify functional
cis-regulatory elements (CREs) and test the hypothesis that trophoblast specification from naïve hPSCs is
primary mediated by transitions between unmarked and actively marked CREs. Aim 2 will define a core
transcriptional circuitry governing human trophoblast specification, starting from the results of a genome-wide
CRISPR/Cas9 knockout screen in hTSCs. We will test the hypothesis that transcription factors (TFs) enriched
at enhancers and promoters of hTSC-specific essential genes constitute an upstream circuitry of trophoblast
inducers and integrate these trophoblast inducers and their target CREs into a dynamic gene regulatory network
during trophoblast specification. Aim 3 will investigate candidate regulators of trophoblast differentiation into EVT
and STB lineages, which perform specialized functions during pregnancy. We hypothesize that the G protein-
coupled receptor CCR7 and the TF TEAD1 are required for EVT differentiation. By generating trophoblast
organoids from CCR7 and TEAD1 knockout hPSC lines, we will delineate a genetic hierarchy of factors regulating
EVT differentiation and invasion. We will also investigate novel regulators of STB differentiation based on their
ability to promote cell cycle exit in hTSCs and their enrichment at STB-specific open chromatin. In summary, this
project will provide conceptual and experimental advances in understanding the genetic and epigenetic
mechanisms regulating specification of the human trophoblast lineage. Our work will also define the action and
significance of CREs and TFs in regulating the differentiation of hTSCs into specialized trophoblast cell types.

Public health relevance
PROJECT NARRATIVE Our understanding of human placental development remains limited since it occurs inside the mother’s womb and animal models inadequately recapitulate human placental physiology. This project combines recently established stem-cell-based approaches with studies of primary first-trimester tissues to investigate the critical genes and heritable phenotype changes that do not alter the DNA sequence (“epigenetics”) underlying human placental development and function. This research will define the action and significance of specific molecules in regulating the specialization of trophoblast progenitors into the diverse cell types found within the human placenta, with implications for understanding implantation failure, preeclampsia, and preterm birth.